Massachusetts AI and Technology Center for Connected Care in Aging and Alzheimer's Disease (MAITC): Pilot Core (Aging Focus)

PROJECT SUMMARY: Aging Pilot Core
The Aging Pilot Core is one of the principal mechanisms by which the Massachusetts AI and Technology
Center for Connected Care in Aging and Alzheimer's Disease (MAITC) will achieve its overarching goal to
develop and test emerging AI-enhanced technologies that promote healthy aging, especially for vulnerable
groups at high risk for health problems and poor quality of life. The Aging Pilot Core will draw on the collective
clinical, scientific, and technical expertise within MAITC and the valuable input of our Stakeholder Core and
Industry Advisory Board to complete the following specific aims: 1) Solicit and select the most meritorious pilot
studies that will develop and test novel AI-enhanced technologies to support the independence, health, and
well-being of older adults; 2) Provide mentorship, oversight, and resource supports for pilot project
investigators; 3) Assist pilot project investigators in refining their research methods and translating their
technologies for clinical, industry, and research use. The Aging Pilot Core Lead (Dr. Margie Lachman) and Co-
investigator (Dr. Julie Lauffenburger) will work with the MAITC’s other core leaders to coordinate and oversee
the pilot project process. The Aging Pilot Core will solicit pilot projects from the training programs, departments,
and centers at universities and research institutions across the nation, drawing on an extensive pool of existing
investigators who have expertise in areas such as gerontology, geriatrics, technology, computer science, and
artificial intelligence. Example aging-related pilot projects include: (1) Increasing and maintaining functional
health and independence in later life by monitoring physical activity and sleep; (2) Improving mental health and
delivery of care via technologies that increase social connectedness; and (3) Improving chronic illness
management through integrated monitoring and telehealth platforms. Once selected, each pilot project leader
will be assigned two mentors who will provide research guidance and facilitate access to needed resources.
The Aging Pilot Core will work with the other MIATC cores and the AITC Coordinating Center to ensure
scientific integrity, rigor and reproducibility, and to facilitate IRB approvals, human subject safety, financial
management, and regulatory approvals. The Aging Pilot Core will help pilot investigators identify critical next
steps to move their innovations closer to clinical and research use. To this end, we will provide resources to
pilot investigators to refine their technologies, make industry contacts, and develop new grant proposals to
accelerate the movement of novel technologies towards the ultimate goal of the Aging Pilot Core—to improve
the care and quality of life for older adults.

Public health relevance
The Massachusetts AI and Technology Center for Connected Care in Aging and Alzheimer's Disease (MAITC) seeks to develop and validate health monitoring devices and artificial intelligence technologies to support healthy aging and Alzheimer's Disease care. The MAITC will play an integral role in eliciting needs from patients, caregivers, and clinicians and supporting research projects aimed at developing new and innovative AI-enhanced technologies to address these needs.